Zebrafish International Resource Center (ZIRC)

Zebrafish is a premiere organism to study vertebrate development, physiology, behavior, genetics, and
disease. Powerful techniques allow efficient generation and recovery of zebrafish mutations affecting genes
that regulate developmental patterning, organogenesis, physiology, and behavior. Recent advances make it
easy to study gene function in transgenic zebrafish and with antisense oligonucleotides. The functions of
many, if not most of these genes are conserved among vertebrate groups. Thus, analysis of zebrafish
mutations provides insights into gene function in other vertebrates, including humans.
The Zebrafish International Resource Center (ZIRC) has been established as a repository that provides
animals, materials, and services to the research community. This proposal seeks continued funding 1) to serve
as a central repository for zebrafish genetic stocks and research materials, 2) to provide consultation and
pathology services, and 3) to develop feeding and nutrition strategies for zebrafish that support ZIRC and
research community husbandry goals. ZIRC materials, services, and husbandry and health standards will be
made widely available to the research community.

Public health relevance
The Zebrafish International Resource Center 1) provides a central repository for zebrafish wild-type, transgenic, and mutated genetic stocks, and other research materials, 2) provides consultation and pathology services, and 3) researches and develops husbandry standards such as the composition of diets, nutrition requirements, and food management strategies that support ZIRC and research community husbandry goals. ZIRC materials, services, and husbandry and health standards will be made widely available to the research community.